Substrate reduction as a novel therapeutic strategy for Glutaric Aciduria Type 1

Project Summary / Abstract
In this project, the investigators propose to develop a novel treatment option for glutaric aciduria type 1
(GA1; MIM 231670). GA1 is an autosomal recessive inborn error of lysine, hydroxylysine and tryptophan
degradation. Patients can present with macrocephaly and may develop a complex movement disorder due to
striatal injury after an acute encephalopathic crisis. The disorder is caused by a deficiency of glutaryl-CoA
dehydrogenase (GCDH), which leads to the accumulation of neurotoxic glutaric acid and 3-hydroxyglutaric
acid. GA1 is considered a treatable disorder and therefore included in newborn screening programs in many
countries. However, current treatment consists of dietary intervention, carnitine supplementation, and
emergency care. This treatment paradigm requires intense efforts from both caregiver and patient. It must be
meticulously maintained, but in some patients neurological disease may still develop. These limitations
demonstrate the need for novel therapeutic options with improved efficacy and convenience. The investigators
hypothesize that by using inhibitors upstream in the lysine degradation pathway, accumulation of neurotoxic
glutaric acid and 3-hydroxyglutaric acid in GA1 can be diverted into more tolerable metabolites. It has been
shown that hyperlysinemia is a biochemical phenotype without clinical significance. It is caused by mutations in
AASS encoding 2-aminoadipic semialdehyde synthase (AASS), which is an enzyme upstream of GCDH in the
lysine degradation pathway. The investigators obtained preliminary data showing that deletion of AASS/Aass
limits metabolite accumulation in cell and mouse models for GA1. This suggests that AASS is a suitable and
potentially safe target for treatment of GA1. Thus, the overall objective of this proposal is to identify novel
small-molecule inhibitors of the lysine-oxoglutarate reductase (LOR) domain of AASS suitable for future
medicinal chemistry optimization. In AIM 1, the investigators will identify enzyme inhibitor candidates through
both a small molecule high-throughput screen (HTS) and computational (virtual) screening using their recently
obtained 2.2Å LOR crystal structure. Then, using structure-based drug design, medicinal chemistry methods
and co-crystallization, they will develop preliminary structure-activity relationships to validate new hit analogs
as drug-like scaffolds. All active hits from the HTS and virtual screening will be further evaluated in AIM 2 in
order to generate a prioritized list of commercial compounds with good medicinal chemistry properties. In AIM
3 selected validated hit molecules will be tested in vitro in cell-based models of GA1 by monitoring established
biomarkers for the inhibition of LOR and the disease. Combined, these three aims will yield not only highly
validated hit inhibitors of LOR that can be further developed for treatment of GA1, but also important additional
data on the biochemistry and physiology of lysine degradation.

Public health relevance
Project Narrative Glutaric aciduria type 1 is a genetic disease of amino acid metabolism. This disorder has been included in newborn screening programs, but the current treatment needs improvement. The investigators have identified a drug target to treat glutaric aciduria type 1 and will develop small molecules that can be used in a translational drug discovery program.